Cardiopulmonary Exercise Testing: Pulmonary Hypertension

to Dr. Oudiz from: Ronald Swerdloff, MD, Department of Medicine, Harbor-UCLA Medical Center Gall Anderson, MD, Medical Director, Harbor-UCLA Medical Center and Associate Dean, UCLA School of Medicine Christina Wang, MD, Program Director, GCRC, Harbor-UCLA Medic._l.Center. PHS 398/2590(Rev.05/01) Page _, LJ ContinuationFormatPage NumberpagesconsecutivelyatthebottomthroughoutheapplicationD. o no_u_stesuffixesuchas3a, 3b.